The Kansas Institute for Precision Medicine

ABSTRACT
The overall objective of the “Kansas Institute for Precision Medicine” (KIPM) COBRE at the University of Kansas
Medical Center (KUMC) is to advance the customization of healthcare through promoting innovative scientific
discoveries. The KIPM COBRE will provide support to advance the mission of KUMC through innovative
mentoring and training programs with a precision medicine theme. The KIPM COBRE will also strengthen the
biomedical research capacity within our region by enhancing the research base and infrastructure/core
capacities. To accomplish this, the KIPM COBRE proposes the following Specific Aims: Specific Aim 1. Recruit
and mentor a group of outstanding junior investigators in diverse disciplines with different disease focus areas
that have a common theme directed toward precision medicine. In a rigorous pre-selection process, five
promising junior investigators (and two alternative investigators) were selected from nearly 20 applicants, all of
which had a research theme directly related to precision medicine. Decisions were based on the content of
research proposals and training potential that were evaluated by our leadership team (including the three PIs of
the proposed COBRE, the senior leadership at KUMC including the Dean, department chairs, and past PIs of
COBREs within KUMC). Each applicant has been assigned at least one internal and one external mentor with
expertise related to their area of study. All COBRE faculty candidates contributed to discussions regarding
infrastructure necessary to enhance their projects via one-on-one meetings with the PIs and research core
directors were formed based in infrastructure needs to enhance their research capacity. Specific Aim 2. To
develop the scientific, technical, mentoring and collaborative infrastructure for a cohesive and sustainable
program in precision medicine. Relying on additional expertise afforded by our Internal Advisory Committee
(IAC), the External Advisory Committee (EAC), and an interactive mentoring program, we will continue to guide
and mentor the next generation of translational scientists to advance molecular medicine in the 21st century with
a thematic focus on precision medicine. Four shared resources, i.e., Administrative, Biomedical Engineering
(BME), Biobanking and Biomarker Validation (BBV), and Quantitative `Omics' (QO) Cores, will be developed to
assist the projects and serve the extended research community in Kansas and beyond. Specific Aim 3. To
foster and enhance collaborations between basic scientists and clinicians and facilitate translational research
directed toward the development of biomarkers, new diagnostics and/or treatments for human disease. Pilot
research projects funded by the School of Medicine, the Departments of Internal Medicine and Pathology and
Laboratory Medicine, and the NCI-designated KU Cancer Center, will provide opportunities to identify both senior
and junior investigators within our institute to expand the breadth and depth of research in the fields of precision
medicine.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Precision medicine holds promise for enhancing best care options at the patient level, thereby closing disparity gaps (caused by inefficient or non-tailored, “one size fits all” therapies) leading to immediate and meaningful impact on population health. The Kansas Institute for Precision Medicine proposed through COBRE funding will provide promising junior investigators, a focused mentoring experience that will help them mature into independently-funded investigators who will contribute to the advancement and clinical realization of precision medicine.